Early predictors of Late Talking (LT) in infancy

Project Summary/Abstract
Infant speech learning during the sensitive period for phonetic learning has been shown repeatedly to
predict language abilities up to school age, with the potential to also mark atypical language
development. One important factor influencing the outcome of the sensitive period and subsequent
language development trajectory is the quality and quantity of language input in infancy. As infants
develop, a substantial subgroup will start to show delay in language emergence, starting around 18
months of age, even after excluding primary factors such as hearing impairment, ASD and other
neurological disorders. Many Late Talkers will have persistent speech and language delays (e.g.,
Developmental Language Disorder) into school age and beyond. Even those who eventually achieve
language scores within the average range still score lower than typically developing children. Late-
talkers might thus provide a first clue of DLD, making them an important group to study. Yet, little is
known regarding their early predictors. In my current parent Katz ESI R01, we are focusing on
investigating whether infants at High Risk of developing DLD (i.e., with first-degree family member
who exhibit speech and language disorders) already demonstrate altered neural processing of
speech at 6, 12 and 14 months of age, straddling the sensitive period, compared to their Low Risk
typically developing counterpart. The parent grant thus offers an optimal infrastructure for this
proposed supplement project to start examining research questions related to early predictors of late
talkers by adding additional measurements at additional time points. Specifically, we plan to examine
two potential early predictors, namely being at High-Risk of DLD and language input in infancy. To
characterize infants’ language abilities in toddlerhood, we plan to recruit all infants (i.e., both Low-
Risk and High-Risk groups) in the parent grant longitudinal study to further enroll in the MacArthur-
Bates Communicative Development Index (CDI) parental reports at 18, 21, 24, 27, 30 months of age.
To characterize language input in infancy (e.g., amount of IDS), we plan to recruit all infants at 9
months of age (i.e., in the middle of the sensitive period) for daylong audio recordings of their home
environment, using the Language Environment Analysis (LENA) system. Together, these additional
measures collected in the supplement project will not only address two important questions regarding
the early predictors of Late Talking, but will also help create a valuable multimodal dataset to share
with the scientific community at the end of the parent grant. Testing these hypotheses will likely open
many opportunities for follow-up questions. For example, in conjunction with the neuroimaging data
collected through the parent grant, we can test if combining language input, infant neural processing
of speech and risk-level can better predict late language emergence than any single factor.

Public health relevance
Project Narrative Infant speech learning has been shown to not only predict their future language acquisition trajectory, but also potentially indicate the onset of atypical language development, including developmental language disorder (DLD) and Late Talking. This proposed supplement project seeks to investigate the predictive potential of two speech-learning related factors in infancy that may indicate Late Talking in toddlerhood, namely risk-level for DLD and language input. By capitalizing on the longitudinal infrastructure of the parent project and generating a multidimensional dataset, this supplement project will offer many future opportunities to further elucidate early predictors of Late Talking, which are foundational to effective early intervention.